NUCLEIC ACID SECONDARY &TERTIARY STRUCTURE

Single stranded RNA sequences adopt folded structures that are dependent on solvent conditions. Rotational dynamics of bound dyes both covalent and intercalated are used to establish hydrodynamic properties to be used in conjunction with NMR data to understand nucleic acid structure and related properties.